Mixed Lineage Kinase 2 (MLK2) in tumor angiogenesis

Project Summary
Cancer is one of the leading causes of death in the USA. The study examines the role of Mixed Lineage
Kinase 2 (MLK2) in tumor angiogenesis, a process vital for cancer growth. Hypoxic condition in solid
tumor activates stress pathway of MLK2. MLK2, abundantly present in the endothelium, is shown to be
essential for endothelial proliferation, migration, and angiogenesis. Lack of MLK2 impairs tumor growth
in mouse models and increases miR-146a levels, which suppresses angiogenic factors like VEGF,
adversely affecting angiogenesis and endothelial cell proliferation. Given that miR-146a overexpression
in endothelial cells leads to similar deficiencies, the study suggests that MLK2's regulatory effect on
miR-146a is crucial for endothelial functions and tumor angiogenesis.

Public health relevance
Project Narrative This project will investigate the role of Mixed Lineage Kinase 2 (MLK2) in endothelial cell function and tumor angiogenesis. By elucidating MLK2's influence on the miR-146a pathway, we aim to uncover new targets for anti-angiogenic therapy in cancer. The outcomes could significantly impact the development of treatments for tumor growth and metastasis.